Multiscale imaging of context-dependent decision-making

PROJECT SUMMARY/ABSTRACT
Real-life decisions are often context-dependent. For example, a motorist may decide to slow down at a
yellow traffic light if a police car is nearby or accelerate if the intersection is empty. The ability to use contextual
information to flexibly guide decisions is a critical component of higher-order cognition that is often impaired in
psychiatric conditions like schizophrenia. To facilitate the identification of potential therapies for these
disorders, scientists have investigated the brain bases of context-dependent decision-making in humans and
animal models. Whole-brain functional magnetic resonance imaging (fMRI) studies in humans have identified
areas in the frontal and parietal cortices that appear to maintain contextual information so it can be used to
guide subsequent decisions. However, fMRI alone cannot reveal the causal and cellular-level roles of these
areas in context-dependent decision-making, and this level of understanding is critical for the development of
novel therapeutics. As such, studying the neurobiology of context maintenance and other higher-order
cognitive processes in mice will be crucial for guiding research on new therapies for human disorders.
However, it is still unclear (1) what areas across the mouse brain contribute to the maintenance of contextual
information and (2) how activity in these areas shapes activity in decision-making regions and behavior. The
aims of this proposal leverage the global coverage of fMRI and the extensive genetic toolkit available in mice to
answer these questions. Aim 1 uses a novel platform for behaving mouse fMRI to image mice as they
complete a task that requires them to maintain contextual information in order to receive rewards. Comparing
brain activity during this task to activity in a nearly identical task that does not rely on contextual information will
identify areas that are involved in the maintenance of contextual information across the brain. Aim 2 uses
optogenetics and two-photon microscopy to silence activity in one of these potential context maintenance
areas to determine how it causally contributes to cellular-level activity in a decision-making area and task
performance. Together, these experiments will unveil new neural substrates of context-dependent decision-
making and suggest potential treatment targets for future pre-clinical studies of psychiatric illness.
This proposal was tailored to both exploit my existing expertise in whole-brain imaging and facilitate my
acquisition of new technical skills and professional competencies that will advance me towards my goal of
becoming an independent physician-scientist. Dr. Michael Shadlen, an expert in perceptual decision-making,
and Dr. Itamar Kahn, an expert in behaving mouse fMRI, are the ideal pair of sponsors for this project, and the
vibrant scientific and clinical communities at Columbia make this the ideal place for me to pursue this training.

Public health relevance
PROJECT NARRATIVE Real-life decisions are often context-dependent- you might decide to grab an umbrella on a sunny day if you heard a forecast of rain or sunglasses if you did not. In this study, I will leverage whole-brain and cellular-level imaging techniques to reveal how the mammalian brain keeps contextual information in mind to flexibly guide decision-making. By advancing our understanding of the neurobiology of this higher-order cognitive process, this proposal will facilitate the identification of new therapeutic targets for psychiatric disorders in which context-dependent decision-making is impaired, including schizophrenia and post-traumatic stress disorder.